Integrating point-of-care urine isoniazid testing into routine care for tuberculosis disease in India to detect medication nonadherence and improve treatment outcomes

Tuberculosis (TB) is the leading infectious cause of death globally. India has the largest TB epidemic,
accounting for one-quarter of cases and one-third of TB deaths worldwide. Nonadherence to medications is a
central challenge in TB care leading to increased death, disease recurrence, and drug resistance. Despite its
importance, detecting nonadherence in routine care is challenging, as current measurement approaches are
inaccurate, not person-centered, or ineffective at improving outcomes. Early and accurate detection of
nonadherence may serve as an entry point for differentiated care, in which people with TB at risk for poor
outcomes can be given intensified interventions. Urine isoniazid testing is a validated, low-cost, point-of-care,
and direct adherence measure that may be predictive of TB outcomes and therefore serve as an ideal triage
test to enable differentiated care. However, to integrate urine testing into routine care, research is needed to:
(1) understand how the test performs at scheduled clinic visits, (2) gain a rich understanding of root causes of
nonadherence to better leverage urine test results, and (3) identify barriers and facilitators to implementation.
In this R01, we propose conducting a prospective cohort study with translational research involving clinical,
behavioral, and implementation science to facilitate integration of urine isoniazid testing into India’s national TB
program. Our central hypothesis is that urine testing can be integrated into routine care to facilitate early and
accurate identification of people with TB who are likely to suffer poor outcomes, including death and TB
recurrence. In Aim 1, we will assess the accuracy of urine test results assessed at scheduled clinic visits in
comparison to those assessed at unannounced home visits. In Aim 2, we will assess the relationship between
nonadherence detected by urine testing and subsequent unfavorable TB outcomes of death, loss to follow-up,
treatment failure, and post-treatment TB recurrence. In Aim 3, we will identify reasons for nonadherence
across the TB treatment course by conducting qualitative interviews with participants in the cohort who are
urine test-negative. We will then conduct a mixed methods analysis by integrating qualitative and quantitative
findings to identify interventions to improve adherence that may be appropriate at different timepoints in TB
treatment. In Aim 4, we will identify implementation factors that can inform integration of urine testing into
routine care by conducting qualitative interviews with people with TB in the cohort study, TB clinic care
providers, and policymakers in India’s TB program. This R01 proposal aims to develop an innovative but
pragmatic strategy for early identification of TB medication nonadherence that is feasible in low- and middle-
income countries with a high TB burden, in a manner that aligns with the NIAID strategic objective of
discovering “novel biomarkers for prediction of TB outcomes.” Our findings will inform a future R01 randomized
trial in which urine testing is used to triage people with TB, to identify those at high risk, as part of an adaptive
differentiated care strategy, which has great potential to improve TB outcomes in India and globally.

Public health relevance
Project Narrative Tuberculosis (TB) is the leading infectious cause of death globally, and TB incidence is particularly high in India, where one-quarter of cases and one-third of TB deaths occur. Nonadherence to TB medications is associated with increased death, disease recurrence, and drug resistance; however, practical approaches for detecting nonadherence in routine TB care are lacking. We propose studying urine isoniazid testing—a low- cost and point-of-care TB medication adherence measure—by evaluating its accuracy and value for predicting subsequent unfavorable TB outcomes, while also identifying reasons for nonadherence and implementation factors that will enable integration of this test into routine care in India’s national TB program.